mHealth Intervention to Support Symptom Communication for Children with Cancer

PROJECT SUMMARY
Inadequately managed symptoms caused by their disease and its treatment result in unnecessary suffering for
children with cancer that interferes with their quality of life and may impact survival. Communication that
emphasizes the child’s self-report and is actionable by the child’s parents and the clinical team is key to
effective symptom management. The early cancer treatment period (ECTP) is a key time to implement
interventions targeting symptom-related communication. Digital health tools, including mobile health (mHealth)
apps are emerging as proposed solutions to support health-related communication between patients and
clinicians. The Office of the National Coordinator for Health Information Technology prioritizes the routine use
of patient-generated health data (PGHD), data recorded by patients that complement clinical data, in clinical
care. Achieving the larger goal of integrating PGHD from mHealth apps into clinical care requires attention to
data security, interoperability standards for data exchange, and representation of data within the electronic
health record (EHR). Integrating PGHD in clinical care also requires attention to facilitators and barriers such
as patient/family adherence to reporting, accessibility of PGHD in the EHR, and clinician engagement. Our
interprofessional team engaged school-age children (6-12 years) with cancer, parents, and clinicians to co-
design Color Me Healthy, a child-centric app that provides an evidence-based structure for children to report
eleven common symptoms, and demonstrated its feasibility and acceptability. Our next critical step to
advance Color Me Healthy to scalable implementation is to develop and evaluate a clinician-facing app that
is interoperable with electronic health record (EHR) systems to integrate review and discussion of children’s
data as part of the clinical workflow. The project will be conducted as an early phase Behavioral Intervention
Development Trial to define and refine key components of implementing Color Me Healthy during the ECTP
with attention to underlying mechanisms of the intervention and to identify and address facilitators and barriers
from perspectives of children, parents, and clinicians. During Aim 1, we will employ user-centered design
methods to develop a Web-based, clinician-facing version of the Color Me Healthy app for EHR integration as
a SMART on FHIR app. Aim 2 will allow us to optimize implementation of Color Me Healthy as an
implementable communications-support intervention in the clinical setting during the ECTP by engaging
children, parents, and clinicians to define and refine key components of the intervention. During Aim 3, we will
conduct a single-site repeated measures trial to evaluate the efficacy of implementing Color Me Healthy in the
ECTP to improve symptom communication. The immediate expected outcome is successful implementation of
an interoperable, scalable SMART® on FHIR app to improve symptom communication during the ECTP. The
proposed work will build a chain of evidence to meet our long-term goal to deliver timely, evidence-based care
to alleviate symptoms and promote quality of life for children with cancer.

Public health relevance
PROJECT NARRATIVE Communication that includes the child’s perspective and can be understood and acted upon by parents and clinicians is key to managing symptoms associated with childhood cancer and its treatment. The proposed project will develop and test an intervention to improve symptom communication during early childhood cancer treatment using Color Me Healthy, a game-based symptom assessment app for children. We will develop and test a clinician-facing version of the app that allows children’s data to be included in the electronic health record to improve communication about children’s symptoms during clinic visits.